Elucidating The Roles of PIK3IP1/TrIP Regulation on Distinct T Cell Subsets in the Context of Cancer

PROJECT SUMMARY
The signaling pathways involving phosphoinositide-3-kinases (PI3Ks) are highly conserved and tightly regulated
to influence the activation, proliferation, and survival of all cell types. PI3K signaling plays a major role in T cell
responses to antigen due to its position directly downstream of T cell receptor (TCR)/CD28 ligation. Our lab has
recently shown that the cell surface protein TrIP (Transmembrane Inhibitor of PI3K, gene name: Pik3ip1) has a
distinctly high expression on T cells and is capable of downregulating PI3K signaling in CD4+ T cells, acting as
a negative regulator of T cell immune responses. These studies revealed that CD4+ T cells lacking TrIP
expression exhibit a more Th1 inflammatory phenotype compared to WT controls both in vivo and in vitro. These
data have led us to propose that TrIP restricts the inflammatory activity of CD8+ T cells, and that
targeting/knockout of this negative regulator may promote anti-tumor immunity. I have already obtained
preliminary data demonstrating that CD8+ T cell-specific TrIP knockout mice (TrIPfl/flE8icre) are resistant to growth
of syngeneic tumors. In addition to increased tumor resistance, we have also found that tumors harvested from
our TrIPfl/flE8icre knockout mice contain twice as many infiltrating T cells compared to their WT counterparts. We
also found that CD8+ T cells were the main drivers of this increased T cell infiltration, as their frequency was
double that of the CD4+ population. These preliminary data are the basis of our proposal aimed at further
elucidating cell-intrinsic effects of TrIP activity in CD8+ T cells, including its impact on antitumor immunity. These
studies will not only improve our understanding of TrIP as a negative immune regulator, but also inform on the
potential for TrIP as a future immunotherapeutic target.

Public health relevance
PROJECT NARRATIVE The discovery and characterization of novel immunotherapy targets is required to improve upon the response rates and overall survival of patients. A novel regulator of T cell activity, TrIP, has been shown to improve anti- tumor immunity in mice, but the mechanisms of these effects are poorly understood. This proposal seeks to explore in more detail the effects of TrIP modulation on individual T cell subsets using tumor models to better evaluate its potential as an immunotherapy target.